Cell and Tissue Analysis Core

CELL AND TISSUE ANALYSIS CORE
PROJECT SUMMARY/ABSTRACT
The overall objective of the Cell and Tissue Analysis Core is to provide diabetes researchers at the University of
Colorado with a unified means to access and effectively use state-of-the art microscopy and mass cytometry
systems to drive innovative research. This necessarily includes providing access to this equipment; expertise
and training to use the equipment effectively for diabetes-related tissues; expertise and validated diabetes-
related resources to prepare samples appropriately; guidance to design experiments; resources to analyze data;
and assistance with its interpretation. Fluorescence microscopy and multi-channel cytometric approaches are
related tools that are central to diabetes research. The availability of higher-end systems that provide important
functionalities is often limited by: 1) the high cost of the systems; 2) the costs and expertise needed to maintain
these systems; 3) the specialist expertise needed to use these systems to effectively collect data; and 4)
validated reagents for diabetes-related analysis. This presents a challenge for diabetes researchers to
incorporate state-of-the-art microscopy and cytometry approaches in their research. The University of Colorado
Anschutz Medical campus possesses state-of-the-art microscopy systems and mass-cytometry systems that
have been acquired through internal investment, external shared instrumentation grants or instrument
development grants. There is also tremendous expertise from expert investigators and highly trained staff. DRC
support provides an opportunity to leverage these resources for diabetes researchers. The mission of this core
is to provide access and enable effective usage of these sophisticated systems so that diabetes researchers can
incorporate innovative approaches, to both maximize research productivity and catalyze new research directions.
We will achieve these goals through the following aims: AIM 1: Enable access to state-of-the-art high-resolution
multi-color confocal microscopy for diabetes researchers; AIM 2: Provide expert assistance to incorporate new
advanced microscopy approaches to enhance diabetes research; AIM 3: Provide access to, and expert
assistance for, state-of-the-art mass cytometry and multiplexed ion beam imaging for diabetes-related
applications; AIM 4: Train diabetes researchers in incorporating new imaging and cytometry technologies in their
research.